Training in Biomechanics in Regenerative Medicine

DESCRIPTION (provided by applicant): The goal of this training program is to provide a solid foundation upon which to build a productive and independent career in Biomechanics in Regenerative Medicine (BiRM). This goal is accomplished via a highly coordinated and mentored interdisciplinary training program with a combination of required and elective courses, research activities, and specialized training opportunities. The proposed Training Program incorporates faculty from the Departments of Bioengineering, Mechanical Engineering, Orthopedic Surgery, Vascular Surgery, Urology, and the McGowan Institute for Regenerative Medicine of the University of Pittsburgh, as well as faculty from the Mechanical and Biomedical Engineering Departments from Carnegie Mellon University. This combination of training faculty research interests and coursework will provide a rich educational experience and more numerous training opportunities for the students than could be obtained within the individual university departments. Moreover, the breadth of research areas that span various physiological systems (cardiovascular, musculo-skeletal, urological) allows for a unique opportunity to train students to become highly skilled problem'solvers while avoiding over specialization. Since the BiRM training program is not central to any one department, its structure permits the student a much wider choice of options with which to pursue a PhD in tissue bioengineering and regeneration. In the current departmental focus of graduate education, a PhD student in one department that wishes to perform thesis research in a laboratory in another department finds many departmental based administrative roadblocks in his/her path. The BiRM program eliminates these roadblocks and permits ever increasing educational options for the students and research collaborations. Coursework includes intensive life science, and biomechanics is utilized to provide the students with a thorough grounding in both areas. Skills acquired in these courses are combined in later courses and the trainees'research.